Core C: Biostatistics and Data Management

Biostatistics and Data Management Core: Project Summary
The translational research projects proposed in this SPORE grant application integrate many different types of
existing and newly generated data, including biological, clinical, demographic, genomic, metabolomic, lipidomic,
molecular, social determinants of health, patient-reported outcomes, and survey and questionnaire data. The
Biostatistics and Data Management Core (Core C) functions as a centralized research design and data
science coordination center for all SPORE projects, bringing together expertise and intellectual resources in
biostatistics, bioinformatics, geospatial data analysis, and data management for SPORE investigators.
Core C members will 1) provide biostatistical and bioinformatics support for rigorous research design and stateof-the-art statistical analysis for all SPORE projects, 2) facilitate state-of-the-art geospatial data analysis for all
SPORE projects, and 3) develop and maintain an integrated database environment for efficient data
management, integration, analysis and sharing for all SPORE research projects, investigators, and participants.
Core C members will work collaboratively with investigators to ensure that the appropriate design is incorporated
into all studies from inception, that data are appropriately validated, linked, cleaned, and analyzed, and that all
results will be interpreted for statistical as well as biological and clinical significance. The Biostatistics and Data
Management Core will work with the Administrative Core (Core A) to assist in preparation of reports, data
management and other administrative duties, with the Biospecimen Processing and Storage Core (Core B)
for management and analysis of specimen-related data, and with Community Outreach and Engagement
Core (Core D) for providing relevant community engagement documents. Fully integrating Core C members into
all SPORE projects and other Cores will build workflow efficiencies and support the translational goals of the
SPORE, while enhancing quality and ensuring scientific integrity of the participating projects. Core C will provide
sophisticated data management, design, and analysis services in order to facilitate important discoveries about
acute lymphoblastic leukemia disparities and to guide future prevention and intervention strategies.

Public health relevance
Public Health Relevance- Biostatistics and Data Management Core The Biostatistics and Data Management Core (Core C) will ensure that the appropriate design is incorporated into all SPORE studies from inception, that data are appropriately validated, linked, cleaned, and analyzed, and that all results will be interpreted for statistical as well as biological and clinical significance. The Core will develop and maintain an integrated database environment for efficient data management, integration, analysis, and sharing for all SPORE projects and investigators.